Understanding the Impact of Dengue Virus Lineage Persistence on Outbreak Potential

Project Summary
New solutions are desperately needed to reduce the annual global burden of dengue. As we have witnessed
for SARS-CoV-2, virus genomics can be harnessed to directly inform public health control measures. However,
for most other pathogens, including dengue virus, the depth of genomic information needed for such
applications is lacking. For dengue virus, part of the issue is its complexity: it is comprised of four genetically
distinct serotypes with many defined genotypes and even more undefined variants. Furthermore, current
surveillance and research programs are not optimized to fully leverage virus genomics. This proposal aims to
bridge this gap by proposing a detailed phylogenetic analysis to uncover critical dengue epidemiological
processes, including the outbreak emergence interval and pattern of spread. Through this initiative, our
understanding of dengue virus diversity, evolution, and epidemiology will significantly advance. The proposed
research, which integrates insights from the COVID-19 pandemic and the 2014-2016 West African Ebola
outbreak, aims to determine which DENV lineages were integral to past outbreaks and explore the temporal
and geographic factors influencing their persistence. The anticipated outcomes encompass the identification of
DENV lineages responsible for causing outbreaks, estimation of average emergence intervals, and insights
into the factors impacting lineage persistence. These findings can revolutionize DENV disease forecasting and
contribute to the development of genomics-informed control strategies, offering a timely and vital approach to
addressing the escalating challenge of dengue transmission globally.

Public health relevance
Project Narrative Dengue virus (DENV) causes millions of infections every year. The development of innovative disease control programs and forecasting methods requires an understanding of which DENV lineages cause outbreaks and of how these lineages spread and persist within communities. Through the proposed aims, we will determine how long it takes for DENV to cause an outbreak from the point of introduction and what environmental factors increase or decrease the time to outbreak.